Elucidating Non-Routine Events Arising from Interhospital Transfers

Veterans experienced more than 3 million emergency department visits in 2021 and nearly one-third of these
are in non-VA settings. Non-VA emergency care is the single largest contributor to community care with an
estimated $500 million in monthly costs. Interhospital transfers are used either to repatriate Veterans during
acute episodes of care or to provide access specialty care (e.g., cardiology) should such skilled services not be
available at the initial hospital. However, such transfers are burdensome for Veterans and their families, and
are associated with worsened clinical outcomes. The field of Human Factors Engineering uses system science
to examine what may contribute to suboptimal clinical outcomes through the evaluation of “Non-Routine
Events.” These are sub-optimal deviations from the standards of care or unexpected events that are identified
through validated surveys of staff, clinicians, and patients.
In this pilot application, we seek to advance the study of Non-Routine Events (NREs) through their application
to interhospital transfers from VA and non-VA emergency departments. We will use validated surveys of NREs
along with transfer documentation to study transfers for evidence of NREs. Finally, in order to automate NRE
data collection, we seek to train an optical character recognition and natural language processing informatics
cool, “MIRROR EHR,” to extract data of NRE components from scanned medical records for Veterans who
experienced interhospital transfers.
Guided by the principles of high reliability, our innovative pilot proposal directly addresses multiple ORD-wide
and HSR&D priority areas including Access to Care, Quality & Safety, and Healthcare Informatics by using
cross-cutting methods of Health Systems Engineering to study interhospital transfers and addressing data
quality and how to integrate non-VA data. This work addresses a major legislative priority of the MISSION Act
to address the quality and safety of non-VA emergency care. The Specific Aims are: 1) Examine Non-Routine
Events arising from interhospital transfers of Veterans; 2) Identify NREs in transferring hospital clinical
documentation amongst Veterans experiencing interhospital transfer; and 3) Demonstrate the feasibility of the
MIRROR EHR informatics tool to collect and categorize data that are indicators of NREs.
The team is uniquely qualified to accomplish these Aims, with expertise in systems science, human factors
engineering, biomedical informatics, implementation science, qualitative methods, and acute hospital-based
care (emergency and hospital medicine). The institutional environment at the VA Tennessee Valley Healthcare
System and Vanderbilt University Medical Center is outstanding, including the Geriatric Research, Education
and Clinical Center (GRECC), a site for VA Quality Scholars, an innovative qualitative research center;
nationally ranked graduate programs in the relevant fields of study; and the national CTSA coordinating center.
This application will conduct necessary pilot work to evaluate the feasibility of NRE data collection arising from
interhospital transfers from both VA and non-VA settings using validated NRE surveys. This is a highly
innovative proposal to advance the methods of safety science and biomedical informatics designed to improve
the quality and safety for Veterans experiencing care transitions in the form of interhospital transfers. Should
this work prove feasible, we plan to use these pilot data to prepare a larger Merit award application to evaluate
NREs in interhospital transfers and to develop interventions to mitigate their potential harm of Veterans.

Public health relevance
Every day, Veterans present for emergency care in both VA and non-VA settings. Veterans may experience interhospital transfers in order to access specialty care or to be admitted at VA Medical Centers. Events, which are sub-optimal, unexpected, and atypical, that occur during these transfers, can frequently occur and are called “Non-Routine Events” and may contribute to adverse events, requiring higher levels of care than expected. In this pilot application, we seek to evaluate the feasibility of studying Non-Routine Events (NREs) through the administration of validated surveys to treating staff and clinicians about transferred Veterans. Finally, we seek to train a novel computer algorithm called “MIRROR EHR” to automate the collection of NRE data from transfer documentation. This pilot work will prepare for a Merit application to improve the safety of emergency interhospital transfers.